WARFARIN AND ASPIRIN IN SECONDARY PREVENTION TRIAL

This is a two-arm, prospective, randomized, unblinded, multicenter trial evaluating the combination of warfarin and aspirin versus aspirin alone in reducing the overall mortality following MI.